Vortex: An open-source library for building real-time optical coherence tomography engines

PROJECT SUMMARY
This proposal seeks to support the Vortex open-source project which meets a progress-limiting
need for software in optical coherence tomography (OCT) research. OCT is a laser-based
imaging technique for real-time in vivo volumetric microscopy that has transformed the
diagnosis and management of eye disease. Modern OCT instruments are complex mechatronic
systems that match carefully designed hardware with application-speciﬁc software to achieve
real-time display of high-quality images. Lack of appropriate software hampers scientiﬁc efforts
as novel OCT hardware requires similarly novel software, although the latter is infrequently the
research focus or subject of publication. We launched the Vortex open-source project to provide
a collection of well-designed and interoperable C++ components which the user can assemble
into application-speciﬁc OCT software in Python or C++. Since development began in 2020,
Vortex-powered software has produced multiple peer-reviewed publications in academic
research and accelerated the technology development process in multiple startup companies.
This proposal now seeks to continue Vortex’s maturation as an open-source library through the
following speciﬁc aims. (1) Restructure Vortex’s memory management scheme to improve
ﬂexibility and functionality. By implementing standards-compliant buffer manipulation routines
following a test-driven development strategy, we will simplify hardware support and lift data type
restrictions for Python bindings. (2) Update Vortex’s Python and logging interfaces to improve
interoperability. In migrating Python bindings from pybind11 to the newer nanobind, we will
standardize memory sharing, eliminate dependencies, streamline integration of logging, and
increase performance. (3) Complete Vortex’s documentation and automated testing suite to
improve usability. Through full documentation of Vortex’s Python bindings and high code
coverage for testing, we will provide an accessible library that is robust and reliable. Work on
each aim will occur in Vortex’s Gitlab public repository, where we will use issues, pull requests,
and milestones to manage the software development process, in accordance with software
industry best practices. We will disseminate these updates to Vortex through public releases on
Gitlab, publication of manuscripts, and presentations/workshops at conferences. Completing
these aims will yield substantial improvements in Vortex from a software engineering
standpoint and produce a library that is both veriﬁably correct and well-documented. We believe
these improvements will position Vortex as a turnkey tool on which OCT researchers and
developers can rely as they advance the state-of-the-art.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because it creates open-source software to support the development of next-generation eye imaging technologies involved in the diagnosis and management of the top three blinding retinal diseases. This project is therefore relevant to the NIH’s mission to protect and improve human health.